Development and Characterization of Small Molecule Activators of Peptidase Neurolysin for Stroke Therapy

SUMMARY
Current stroke research focuses more on understanding the brain’s self-protective and repair mechanisms. Detailed
elucidation of these mechanisms is crucial as such knowledge could lead to development of therapeutic interventions which
mimic or engage the brain’s self-protective/repair mechanisms and can lead to successful stroke therapy. With the proposed
research we seek to develop potent and selective ‘drug-like’ small molecule activators of peptidase neurolysin (Nln) which
will be used as research tools and lead chemical entities to address the critical unmet need for stroke treatments. Our recently
published and pilot studies have identified Nln as a leading brain self-protective mechanism, functioning towards
cerbroprotection and recovery after stroke. Functional significance of Nln in the post-stroke brain is based on its ability to
inactivate several neurotoxic peptides and generate three cerebro-protective/regenerative peptides, which are known from
numerous experimental and clinical studies to critically contribute to the outcome of stroke. Based on this evidence we view
Nln as a central peptidase involved in protection of the brain following stroke. In this collaborative renewal application, we
will leverage our expertise in multiple aspects of the drug discovery process to further optimize lead molecules of two
distinct chemotypes, developed during the first cycle of this R01 grant, to improve their potency and ‘drug-like’ properties
for selective activation of Nln as experimental therapeutic agents for cerebroprotection after ischemic stroke. This proposal
has been formulated based on our compelling experimental data revealing the discovery of two diverse Nln activator
chemotypes that bind to Nln and enhance its catalytic activity; extensive structure-activity relationship, hit-to-lead
optimization and pharmacokinetic studies; and initial in vivo proof-of-concept efficacy studies, in two mouse models of
ischemic stroke, demonstrating the cerebroprotective effects of a lead Nln activator. The goals of this proposal will be
accomplished in three well-integrated aims: (1) conduct lead optimization to further refine activity and ‘drug-like’ properties
of Nln activators; (2) perform biochemical and structural studies to characterize the activation mechanism that the identified
Nln activators exploit; (3) determine the therapeutic potential of Nln activators in post-stroke cerebroprotection using two
mouse models of ischemic stroke. This work is highly innovative because our multi-mechanism molecules are the first and
only Nln activators described in the scientific and patent literature, and the therapeutic potential of such compounds has not
been recognized before. The collaborative investigative team, comprising experts in medicinal chemistry and drug
discovery, cryo-EM and structural biology, enzyme biochemistry and pharmacology, blood-brain barrier physiology and
stroke pharmacology, is highly qualified to conduct the proposed studies. Our long-term goal is to translate the lead Nln
activators from bench to bedside and develop an effective stroke therapy, which will transform the current treatment
modalities for a vast number of stroke patients.

Public health relevance
NARRATIVE Stroke is a leading cause of death and long-term disability in the U.S. with an unmet need for efficacious treatments that can be utilized in a large number of patients. In this proposal we plan to further develop potent and selective ‘drug-like’ small molecule activators of peptidase neurolysin (Nln) which will be used as research tools and lead chemical entities for the treatment of ischemic stroke. In addition, the knowledge about the mechanism(s) governing activation of this cerebro- protective peptidase by small molecules and the design of potent and selective ‘drug-like’ small molecule activators of Nln could be translated to other peptidases and enzymes, activation of which could bear additional therapeutic potential.